Gen-AI Airway Simulator for 3D Endoscopy

ABSTRACT
Endoscopy plays a vital role in the diagnosis and treatment of various medical conditions and is regularly
performed millions of times every year. However, endoscopy is both challenging to perform and often time-
consuming to analyze from the resultant videos. Thus researchers have focused on developing many assistive
and intelligent techniques to aid physicians in conducting endoscopies and to analyze the data. These techniques
all share a common fundamental problem of 3D perception, i.e. recovering the 3D structure of the surveyed
organ and localizing the endoscope in it from the captured 2D videos only. However current 3D perception
techniques perform poorly on real clinical data. One key reason for failure is the lack of high-quality training
data with 3D supervision for training 3D perception systems with Machine Learning algorithms. Current 3D
perception systems rely on simple virtual models that cannot model complex geometric and reflective properties
of internal organs, e.g. airway.
In this proposal, we focus on developing a generative AI-based phantom airway model that can generate
arbitrary geometric shapes and reflective properties of the mucus-layered airway surface conditioned on
covariates such as age, sex, weight, and abnormalities. We aim to learn this generative airway phantom model
from n=300 CT scans and n=300 endoscopy videos of different patients captured at UNC Chapel Hill. We first
focus on designing a novel neural architecture that can generate realistic shapes from global and local latent
codes with covariates, and a novel loss function that trains this generative model from CT scans and endoscopy
videos (Aim 1). We then develop a novel strategy that can render realistic endoscopy videos by optimizing the
material reflectance property modeling the mucus layered airway surface (Aim 2). We will demonstrate the
effectiveness of our proposed generative-AI airway simulator by training state-of-the-art 3D perception systems
on our simulator and existing virtual airway model BronchoPose dataset, and testing these 3D perception
models on n=30 paired endoscopy videos with associated 3D CT scans.
In summary, our proposed generative-AI-based airway simulator aims to provide high-quality realistic training
data for various 3D perception systems. This will help in significantly improving various assistive and
intelligent technologies, e.g. semi-autonomous navigation, 3D visualization, guidance to unsurveyed regions,
automatic extraction of geometric properties, etc., for conducting and analyzing endoscopy and will help in
incorporating these technologies into successful clinical practices. While we focus on the airway, our approach
is general and can be used for building simulators of other organs of interest for endoscopy, e.g. GI tract.

Public health relevance
PROJECT NARRATIVE Intelligent assistive technologies for aiding physicians in conducting and analyzing endoscopy require accurate 3D perception systems which currently fall short due to a lack of high-quality training data. In this proposal, we develop a novel generative-AI-based airway simulator that can generate realistic shapes and render realistic endoscopy videos conditioned on covariates such as age, sex, weight, and abnormalities. Our goal is to demonstrate that this gen-AI airway simulator provides significantly better training data and significantly improves the performance of 3D perception systems for example to facilitate faithful reconstructions of 3D geometry from endoscopy videos..